Wearable Multi-Gas Technologies for Monitoring Personal Air Quality

Frequent and fast assessment of air quality is critical to identify and address potential
exposure to toxic gases that may impact health. However, current methods for monitoring toxic
gases have significant disadvantages that discourage users. Platypus Technologies has developed
a customizable solution for quantitative assessment of gaseous air pollutants which is simple and
low-cost for the consumer market, yet it is robust and highly accurate, allowing for applications in
professional industrial hygiene.
Our novel platform for detection and measurement of toxic gases consist of three
components: (1) disposable sensor chips that produce an optical change when exposed to a specific
toxic gas, (2) a reusable, wearable electronic badge, with wireless capabilities, that reads the optical
state of the sensor chips and alerts the user of the presence of noxious gases, and (3) a software
application for remote communication with the badge, data visualization and data logging. This
multi-gas monitoring platform produces visual, auditory, and vibratory alarms when noxious levels
of toxic gases are detected, enables accurate measurements of gaseous air pollutants, allows for
easy documentation of exposure data, and does not require maintenance or calibration.
Having developed successful prototypes of the technology, we aim to leverage prior
investments in the company and, through this Fast-Track SBIR project, finalize development to
accelerate commercialization of these technologies. We focus the next phase of our work on
selected gases relevant for air quality at home, outdoors, and in the workplace: formaldehyde,
hydrogen sulfide, and peracetic acid. However, successful completion of the goals defined on this
project will facilitate subsequent commercialization of additional sensor chips for other air
pollutants (e.g. ozone, polycyclic aromatic hydrocarbons, chlorine, etc.). In Phase I, we aim to
develop repeatable and scalable fabrication processes that enable measurements of toxic gases with
accuracy requirements in line with federal and industrial standards. In Phase II, we aim to
demonstrate robust device performance over diverse field environments, and to assess user
acceptance of the technology.
Platypus Technologies aims to usher a new paradigm in air quality monitoring by offering
simple, inexpensive, and reliable tools to measure toxic gases. These technologies will enable fast,
frequent air quality monitoring that could lead to improved knowledge of toxic gas exposure at
home and in the workplace, and in turn accelerate decision-making on personal air quality.

Public health relevance
Identification of toxic air pollutants and personal exposure monitoring are two essential actions to mitigate health risks, but current technologies do not meet the needs of citizen scientists or industrial hygienists. Frequent and fast air pollution analysis could enable widespread air monitoring, leading to improved knowledge of toxic gas exposure at home and at work, and enabling individuals to make informed decisions about their lives and the lives of those around them. Platypus Technologies aims to usher this paradigm shift in air quality monitoring by offering wearable, simple, inexpensive, and reliable tools to measure toxic gases.